New York Regional Center for Diabetes Translation Research

Latino Network for Diabetes Translation Research – A National Resource Core
The Latino population is the largest ethnic/racial minority group in the U.S. and is projected to continue to
grow, as the U.S. transitions to a “majority-minority nation.” Latinos clearly bear a disproportionate burden
of diabetes, as compared to non-Hispanic whites. The landmark Hispanic Community Health Study/Study of
Latinos (HCHS/SOL) of 16,415 Latino adults from four U.S. field centers showed an overall diabetes
prevalence of 16.9% with more than 41% undiagnosed, and low levels of diabetes control. The causes of
Latino diabetes disparities include social determinants with their roots in structural racism, as well as
psychosocial, lifestyle, biological and genetic pathways. To combat diabetes disparities and improve quality of
life in US Latinos, innovative, culturally appropriate approaches are needed that address multi-level targets,
partner with community entities, and apply state of science technologies. In the proposed renewal of the New
York Regional Center for Diabetes Translation Research (NY-CDTR), we will build on our successful Latino
Network for Diabetes Translation Research – a National Resource Core (“Latino Network Core”) supporting
type 2 to 4 translational research that focuses on cutting-edge diabetes prevention and management
approaches with emphasis on sociocultural adaptation for U.S. Latinos. We will continue to leverage resources
and expertise of the HCHS/SOL which now includes six years of longitudinal follow-up (with a third, 12-year
follow-up in process) and rich phenotypic and genetic data from multiple ancillary studies relevant to diabetes
translational research across the life course. In addition, we expand the Latino Network Core’s investigator
expertise in culturally appropriate interventions targeting diabetes prevention, management, and healthcare
services. Expertise in cultural tailoring, community engaged research, eHealth approaches, and the use of
pragmatic interventions in real-world healthcare contexts will help guide maximally effective, sustainable, and
innovative translational research in Latinos. In this cycle, we seek to: 1) Further develop the Latino Network
Core, building national capacity for diabetes translational research among Latinos, by engaging new members
(with special emphasis on early stage investigators and those who are underrepresented in medicine), leading
research dissemination and training activities, and convening scientific interest group discussions and themed
meetings; 2) Foster novel research focused on understanding Latino diabetes health and disparities and
identifying modifiable targets for intervention, by facilitating access to the richly characterized HCHS/SOL
datasets and other resources; and 3) Provide consultation and mentorship on study conceptualization, design,
assessment, and evaluation for type 2 to 4 translational research on diabetes prevention, management, and
healthcare services in Latinos. By capitalizing on HCHS/SOL resources and our specialized expertise in
culturally informed interventions to improve health and healthcare among Latinos with or at risk for diabetes,
the evolved Latino Network Core will significantly extend the reach and impact of the NY-CDTR in promoting
type 2 to 4 diabetes translational research at the national level.